Development Research Program

Developmental Research Program: Project Summary/Abstract
This SPORE in Melanoma Developmental Research Program (DRP) serves to identify and fund pilot projects
that take maximum advantage of new research breakthroughs and novel ideas that may eventually reduce the
incidence and morbidity or increase the survival of patients with melanoma. Progress in understanding of
melanoma biology and the role of immune response in melanoma patient outcomes has led to substantial
advances in both targeted and immunotherapies for melanoma patients, and much promise is held for
immediate future advances. Therefore, we are particularly interested in leveraging novel ideas from
investigators with a variety of expertise in this DRP, and providing seed money for testing creative hypotheses
and obtaining preliminary data for projects that are not supported by current or alternative funding sources.
High risk/high reward pilot projects are especially prioritized, and applications from women and minority or
underserved investigators are strongly encouraged. The available DRP funds include the required $50,000
annually throughout the duration of the SPORE award, as well as an annual contribution of up to $100,000
from institutional “matching funds,” for a total of $150,000 per year. Applications for SPORE DRPs are solicited
annually, with an aim to fund at least 3 one-year awards of up to $50,000 each, with the possibility of ongoing
support for a second year award of $50,000 if requested and approved based on acceptable progress.
Philanthropic funds will also be utilized if available to support high quality proposals. Projects that provide a
“pipeline” of additional value to the main SPORE projects or that support other new or concurrent melanoma
grants are welcomed.

Public health relevance
Developmental Research Program: Narrative The Developmental Research Program is designed to solicit, evaluate, and award funds to support novel projects focused on melanoma biology, prevention, and patient treatment. This program will span the full duration of the parent grant, aiming to supporting at least three one- to two-year awards per year at a maximum of $50,000/year for each award. Awardees are expected to present their research at our research seminars, and be included in all activities as part of our effort to develop additional novel projects and approaches. SPORE leaders will help develop successful projects into full grants or future SPORE projects. Our scope includes both cutaneous and uveal melanoma.